Phase II of BUILDing SCHOLARS - Research Enrichment Core

This component of the grant, requested by the University of Texas at El Paso (UTEP), will focus efforts to
support the Research Enrichment Core (REC) of BUILDing SCHOLARS Phase II. The goal of the REC is to
broaden participation in biomedical research careers by involving students in transformative undergraduate
research experiences, engaging students and faculty in impactful mentoring and professional development,
and providing professional development opportunities to faculty so they may enrich the research opportunities
available to students. The REC specific aims are as follows: (1) continue to engage Pipeline Partner
undergraduates in intensive research experiences and broaden the impact of the program to area high school
teachers and Pipeline Partner faculty by including them in research experiences; (2) increase the research
productivity of UTEP faculty by restructuring faculty research-incentive programs; (3) enhance BUILD trainee
professional development and social support systems by refining the Research and Teaching Integration (RTI)
and Peer Mentoring programs; and (4) disseminate program findings associated with the impact that
mentoring, undergraduate research, and the Research and Teaching Integration programs have on the
success and trajectory of participating students and faculty in the biomedical sciences. The first aim will be
achieved by engaging undergraduate students from regional 2-or 4-year PP institutions in intensive research
experiences through the Summer Research Program (SRP) at UTEP. The first aim also expands the summer
research experiences at UTEP to include high school STEM teachers and 2-or 4-year pipeline partner faculty,
through the Research Experiences for Lecturers and Teachers (RELaTe) program. The second aim will be
achieved by establishing and institutionalizing the BUILD ADVANCE grant-writing program that allows release
time for five UTEP faculty members every year to support the development of competitive NIH grant proposals.
The third aim will be achieved by refining the Peer Mentoring program and the Research and Teaching
Integration (RTI) program by enhancing the successful components of these programs developed in Phase I of
BUILD. The fourth aim will be achieved by disseminating the program’s outcomes and other research findings
through internal communication tools, annual partners meetings, publications, conference presentations, and
a BUILDing SCHOLARS conference at UTEP in Fall 2019. These activities are innovative because they will
not only improve the quality of mentored research experiences for undergraduate students and opportunities
for development of BUILD affiliated faculty, but also broaden the opportunity to other regional participants. In
terms of significance, the REC will address the diversity challenge at the societal, regional (US Southwest) and
institutional levels by continuing to implement programs that target the undergraduate populations of
Southwest Texas, Arizona and New Mexico. Ultimately, through these varied initiatives, the REC will enrich the
research capacity and diversity of the biomedical workforce and address regional health disparities.

Public health relevance
The public health relevance of the REC lies in the enrichment of research activities for faculty and students in the biomedical workforce. The innovative and impactful programs for both students and faculty will be refined and validated as transformative models for increasing diversity in the biomedical workforce in Phase II of BUILDing SCHOLARS. This will allow the successful models developed in BUILDing SCHOLARS to be disseminated and adopted at multiple institutions and increase the diversity of groups trained to enter the NIH funded workforce nationally. Supporting a more diverse biomedical workforce will improve the access and quality of educational opportunities to all students, include more perspectives in the research community, and enrich the capacity of this community to decrease health disparities.